Mechanism and therapeutic implication of RNA-modification-mediated codon-biased translation in acute myeloid leukemia

PROJECT SUMMARY:
Among the 20 standard amino acids encoded by 61 codons, 18 are encoded by multiple synonymous codons.
However, the synonymous codon usage is not random, as different organisms or different genes in an organism
prefer using different synonymous codons; such a phenomenon is called codon bias. A mechanism, termed
codon-biased translation, which involves adapting tRNA pools to meet the demands of translating stress-
response mRNAs that utilize biased codons, is hijacked by cancer cells to support their survival/proliferation and
therapeutic resistance, via facilitating the synthesis of essential oncogenic proteins with biased codons.
However, the detailed mechanisms remain poorly understood. Acute myeloid leukemia (AML) is a type of
common and fatal hematopoietic malignancies and over 70% of AML patients cannot survive over 5 years. Thus,
there is a critical unmet clinical need to elucidate the molecular mechanisms driving leukemogenesis,
particularly those governing leukemia stem/initiating cell (LSC/LIC) self-renewal and drug resistance, to develop
more effective therapeutic strategies to treat unfavorable-risk AMLs. Our preliminary data suggests that ALKBH1,
a Fe(II)/α-ketoglutarate (α-KG)-dependent dioxygenase, likely plays an essential tumor-promoting role in AML.
Alkbh1 deletion significantly inhibited AML development and LSC/LIC self-renewal in the MLL-AF9-induced AML
model. Notably, we revealed that ALKBH1 is totally dispensable for normal hematopoiesis, highlighting a unique
therapeutic opportunity to target ALKBH1 in AML. Interestingly, our preliminary data suggests that ALKBH1 is
likely a key regulator of codon-biased translation in AML through promoting RNA 5-formylcytosine (f5C)
modification and thus facilitating codon-biased translation of oncogenic targets such as WDR43, which in turn
likely promotes AML development/progression, LSC/LIC self-renewal and resistance to venetoclax (a potent
BCL2 inhibitor). Based on our preliminary results, we hypothesize
in
codon-biased
especially
Aims
that ALKBH 1 orchestrates C modifications
tRNA and mRNA, facilitating LSC/LIC self-renewal and driving AML initiation and progression via f 5 C-mediated
translation, and that targeting ALKBH1 represents a promising therapeutic strategy , alone and
in combination with venetoclax, in treating AML by eradicating LSCs/LICs . We propose three Specific
to test our central hypothesis: (1)
f5
Determine the role of ALKBH1 in AML pathogenesis and drug response;
(2) Decipher the RNA-modification-related mechanism by which ALKBH1 facilitates codon-biased translation in
AML; and (3) Evaluate the therapeutic potential and underlying mechanism(s) of pharmacologically targeting
ALKBH1 in AML. Overall, our proposed studies will substantially advance our understanding of the fundamental
biology and underlying molecular mechanism(s) of ALKBH1-mediated epitranscriptomic (RNA modification)
changes in tRNA and mRNA and their crosstalk in facilitating codon-biased translation, leukemogenesis and
drug resistance. This project will also lead to the development of effective novel strategies to treat unfavorable-
risk AMLs by targeting ALKBH1 signaling. Thus, our project is of high novelty and translational significance.

Public health relevance
Project Narrative: Codon-biased translation is utilized by cancer cells to support their survival/proliferation and resistance to therapies, through facilitating the synthesis of essential oncogenic proteins with biased codons, but the detailed mechanisms remain poorly understood. In addition, despite considerable improvement in treatment-adapted strategies, the five-year overall survival rate of acute myeloid leukemia (AML) patients is still lower than 30%, and thus there is a critical unmet medical need to identify new therapeutic target(s) and develop improved therapeutics. This proposal aims to determine the role of ALKBH1 in AML pathogenesis, and to delineate the molecular mechanism(s) by which ALKBH1 catalyzes chemical modifications (e.g., 5-formylcytosine (f5C)) in transfer RNA (tRNA) and messenger RNA (mRNA) whose crosstalk facilitates codon-biased translation and thereby promotes AML development/progression, leukemia stem/initiating cell (LSC/LIC) self-renewal and resistance to venetoclax (a potent BCL2 inhibitor); moreover, we will also develop novel effective strategies to treat unfavorable-risk AMLs by pharmacologically targeting ALKBH1 signaling alone and especially in combination with venetoclax-based therapy.